Identification of the specific risk allele responsible for oxidative stress in ARMS2/HTRA1-related AMD

PROJECT SUMMARY
Until now, CRISPR has not been readily applied to isolate linked genome-wide association studies (GWAS) alleles as
Cas9 tends to re-cut the donor template. Our project will be the first to establish that CRISPR-edited cells can be
used to isolate closely linked alleles in a GWAS-associated disease. Furthermore, research on age-related
conditions uses traditional cultured cells as the metabolic backdrop for studies. Given that these rapidly proliferating cells
more closely resemble embryonic cells than aged adult cells, they likely do not provide the appropriate environment to
study the molecular biology of aging. Here, we propose to use cells that have been pharmacologically aged, enabling
our model to better recapitulate the conditions present in the older adult eye, and ultimately identify appropriate areas of
intervention. By using this innovative approach, we will develop a patient-specific disease model to test not only the
particular mutations addressed in this application, but also other mutations and, potentially, other age-related retinal
diseases down the road.

Public health relevance
PROJECT NARRATIVE Our pharmacologically aged genotype-specific ARMS2-HTRA1 RPE cell lines will be used to identify the alleles responsible for age related macular degeneration.